Interactive Effects of Aging and Blast Exposure on Central Auditory System

Many blast-exposed Veterans report difficulty in complex listening situations (e.g., understanding speech in
noise) despite normal or near-normal performance on standard audiological tests. This suggests a deficit in
central auditory processing. Indeed, blast-exposed Veterans perform abnormally on central auditory tests,
particularly those assessing temporal processing. A similar pattern is observed in middle age adults who often
have good peripheral hearing but show deficits on tests of temporal processing and speech understanding in
noise. Age-related auditory deficits have been linked to functional and anatomical changes in the central
auditory system. The physiologic origin of auditory deficits in blast-exposure is currently unknown, although the
similarity in behavioral profiles between aging and blast exposure suggests similar mechanisms may be
affected. It is therefore possible that the auditory deficits experienced by blast-exposed Veterans will intensify
as they enter middle age and beyond. This has not been investigated systematically. The present study will
determine: (a) whether there is an interaction between aging and blast exposure on temporal processing and
speech recognition (Specific Aim 1); (b) whether age- and/or blast-related differences in behavioral
performance can be linked to neuroanatomical changes within or outside the auditory system (Specific Aim
2); and (c) whether aging, blast exposure, or their interaction lead to changes in functional representations of
speech in the auditory cortex (Specific Aim 3). Groups of 50 blast-exposed and 50 unexposed Veterans will
be tested. Young (18-39 years) and middle age (40-60 years) Veterans will be represented in equal numbers
within each blast exposure group. Each participant will be assessed on a number of temporal processing and
speech recognition tests known to reveal deficits in middle age listeners. Gray and white matter morphology
will be assessed using T1- and diffusion-weighted magnetic resonance imaging (MRI). Finally, cortical activity
will be measured during a competing speech task using functional MRI. We hypothesize that aging and blast
exposure will produce interactive effects on performance in temporal processing and speech tests, and that
performance will be linked to changes in the structural and functional integrity of the central auditory nervous
system. We will test for alternatives, e.g., that auditory performance is linked to cognitive ability or brain health
outside the auditory system. We expect our findings will: (a) lead to improvements in diagnosis and
classification of central auditory deficits; and (b) motivate focused rehabilitation strategies. This study will build
on the candidate’s previous research using psychophysical and neuroimaging techniques to examine speech
processing in listeners with normal hearing and sensorineural hearing loss. A strong mentorship team will
contribute to research and career development. Dr. Marjorie Leek is the primary mentor and will provide
guidance on behavioral testing in clinical populations (particularly blast exposure) and general oversight of the
career development plan. Co-mentor Dr. Barbara Holshouser will coordinate imaging activities and provide
expert training in neuroimaging including advanced imaging modalities, post-processing, and MR physics. Co-
mentor Dr. Bruce Lyeth will provide research education in experimental traumatic brain injury (TBI) research.
Co-mentor Dr. Grace Lee will provide training in cognitive assessment. Drs. Joseph Helpern and Christopher
Stecker will provide consultation in diffusion-weighted imaging and functional auditory imaging, respectively.
Training activities will include: workshops on grant writing, imaging methods, and TBI; consultation with
research groups and clinicians involved in neuropsychology, audiology and TBI; and visits to Dr. Lyeth’s
laboratory. The candidate will apply for NIH R01 and VA RR&D Merit Award funding toward the end of the
award period. The candidate’s short-term career goals are to gain experience with new clinical populations,
learn new neuroimaging modalities, and establish a background in TBI research. The candidate’s long-term
career goal is to become an independent VA investigator in auditory rehabilitation science.

Public health relevance
One of the most common sources of injury in the modern era of warfare is exposure to high intensity blasts/explosions. At least 100,000 Veterans of the conflicts in Iraq and Afghanistan have experienced a blast- related mild traumatic brain injury. Increasing numbers of these blast-exposed Veterans have been reporting to VA audiology clinics with debilitating auditory problems including difficulty understanding speech in background noise. Puzzlingly, peripheral hearing thresholds are normal or near-normal in many cases. Efforts to diagnose, classify, and treat blast-related hearing deficits have achieved limited success because the physiologic origins of these deficits are not understood. Moreover, it is not known how blast-related auditory deficits will be affected by normal age-related declines in auditory and cognitive processing or vice versa. This study will use a combination of behavioral and neuroimaging methods to investigate how age- and blast-related changes within and outside the auditory system contribute to problems with auditory communication.